Emory Specialized Center of Research Excellence (SCORE) on Sex Differences

PROJECT SUMMARY / ABSTRACT – Project 2 (Brain)
Sex hormones are influential in setting the tone of immune responses and estradiol exhibits a particularly
strong influence that varies across the life cycle in women. Although largely anti-inflammatory and protective,
estradiol can have divergent effects and the influence and availability of estradiol changes with aging, most
notably with the menopause transition. Furthermore, exposure to stressors such as trauma can impact the
functions of sex hormones, including estradiol, as well as contribute to systemic inflammation through gut
barrier dysfunction and reduced microbiota diversity. Project 2 will address the overarching hypothesis that
PTSD and menopause interact to precipitate alterations in the brain, bone, and heart that are associated with
alterations in ER function and peripheral inflammation secondary to gut dysfunction and dysbiosis. We will
assess the interactions among neuroendocrine regulatory interactions with ‘leaky gut metrics’ and general
systemic inflammation, and risk for acceleration of adverse effects on bone, brain, and heart health. The
planned research will evaluate the associations among estrogen receptor expression and ex vivo anti-
inflammatory actions with peripheral cytokines, gut barrier dysfunction, reduced gut microbiota species, and
markers of brain health, including circulating neurofilament light chain and cognitive function, across the
menopause transition. We will also conduct clinical interviews to assess trauma exposure and PTSD to
examine how these psychosocial factors interact with social support to exacerbate and mitigate estrogen
deficiency and inflammation on negative outcomes in end organ systems including changes in cognition
(Project 2: Brain), bone mineral density (Project 1: Bone) and endothelial dysfunction, arterial stiffness, and
coronary atherosclerosis (Project 3: Heart) from Cycle 1 to Cycle 2 of the Emory SCORE. Overall, our studies
will increase our understanding of the protective role of social support in prevention of inflammation-related,
non-AIDS age-related comorbidities (NACMs) in a highly trauma-exposed group of women living with HIV and
at risk for HIV and provide foundational knowledge describing the interaction of trauma history and
reproductive senescence on multi-system aging that may have implications for understanding interactions in
multiple diseases and disorders beyond the study of HIV.

Public health relevance
NARRATIVE – Project 2 (Brain) Although largely anti-inflammatory and protective, estradiol in women can have divergent effects that may be influenced by aging and psychosocial factors, including HIV, trauma, posttraumatic stress disorder (PTSD), and social support. The current study aims to investigate the impact of trauma exposure, PTSD, and social support on the development of inflammation via gut dysfunction and co-morbid adverse health outcomes impacting bone, brain, and heart health in the context of immunosenescence and endocrinesenescence in women living with HIV and women at risk for HIV.